Validation and Application of a Model for Human-like TB Latency in Rabbits

Project 2 will validate a model of human-like TB latency in New Zealand White rabbits, and apply this model to test interventions against latent TB infections (LTBl). The world's latently infected population comprises the reservoir which feeds the global tuberculosis TB epidemic. Novel approaches to treat latent infections would contribute greatly to TB eradication. There is a critical need to develop an animal model that reflects the human spectrum of latency. The mouse is a poor model for LTBl; and our preliminary data and work by others suggests that

Public health relevance
Tuberculosis hides within humans in a form called latency, only to remerge years to decades later and make people sick. How this happens is poorly understood. This proposal will develop new ways to kill latent tuberculosis which would contribute greatly to tuberculosis control and eventual eradication.